Physiology of bacterial metabolism in the human gut microbiome

Summary:
This application is for an administrative supplement to enhance diversity in health-related research under the
aims of the parent grant, “Physiology of bacterial metabolism in the human gut microbiome” (GM142873). The
supplemental funds will provide support for Dr. Michelle Miranda-Velez, a post-doctoral scholar in the PI’s
laboratory. Dr. Miranda-Velez has extensive expertise in chemistry, synthesizing polymers with biological
activity against Mycobacteria. The current supplement will provide a rigorous research training experience for
Dr. Miranda-Velez in the biochemistry and physiology of the human gut microbiota. In addition, it will provide
an individualized mentorship and career development plan designed to support Dr. Miranda-Velez as she
follows her chosen career path to start her own independent research group at a US academic institution.
While advancing the NIH mission for enhancing diversity, the proposed supplement will also enhance the goals
of the parent grant.

Public health relevance
Project Narrative: The goal of this supplement is to promote diversity in health-related research through the training and mentorship of Dr. Michelle Miranda-Velez, a Latina post-doctoral scholar in the PI’s laboratory. Research proposed under this supplement will be an integral component of the parent ESI MIRA grant (GM142873) with the goal of characterizing the pathway for anaerobic uric acid metabolism by gut bacteria which compensates for loss of uricase in humans. Results from this supplement, which does not involve animal studies, will provide important research experience, mentorship, and career development opportunities for the post-doctoral candidate, while advancing the aims of the parent proposal.